Equipment supplement for grant R01 GM072540 Assembly and Function of the Yeast Spore Wall.

PROJECT SUMMARY/ABSTRACT (taken from the parent grant)
Fungal infections are a significant public health problem because they can be
lethal in immunocompromised individuals. A major difficulty in treating these infections is
the small number of effective antifungal drugs. Existing treatments cause significant side
effects and frequently result in the appearance of resistant strains. The cell wall is an
essential organelle of a fungal cell and contains many fungal-specific components that
are potential targets for anti-fungal drugs. For example, one major class of antifungal
drugs targets a key enzyme in cell wall assembly. Therefore, understanding how the cell
wall is constructed is essential for identifying new targets for antifungal drugs. In the
budding yeast Saccharomyces cerevisiae, the haploid genomes produced by meiosis
are encapsulated by a multi-layered spore wall, which allows spores to resist a variety of
environmental stresses. The inner layers of the spore wall are composed of mannan and
β-glucan, similar to the vegetative cell wall. The outer layers of the spore wall are
comprised of the polysaccharide chitosan, the polyphenol dityrosine and triglycerides.
These outer spore wall components are absent from vegetative cell walls and are
primarily responsible for the stress resistance of spores. The combination of (1)
chitosan, (2) a polyphenol, and (3) neutral lipids is a conserved structural module in
fungal cell walls, including those of pathogenic fungi. The budding yeast spore wall
therefore provides an excellent model system to study the construction and regulation of
this structural module. This grant is focused on how a conserved set of lipid-droplet
localized proteins regulates the assembly of this fungal cell wall structural module both in
S. cerevisiae and the pathogen Candida dubliniensis.

Public health relevance
PROJECT NARRATIVE (taken from parent grant) The fungal cell wall is the interface between the cell and its environment. In pathogenic fungi, proper function of the cell wall is important for survival in the host, and drugs targeting cell wall assembly are effective antifungal agents. The spores of baker's yeast Saccharomyces cerevisiae are not pathogenic but are surrounded by a complex coat, the spore wall, which includes many of the same components found in the walls of pathogenic fungi. We are using spore wall formation as a model system to unravel the biochemistry and genetics of fungal wall assembly. This application focuses on understanding how a conserved set of proteins localized on lipid droplets promote the formation of a specific structural feature in the cell wall.